Statistical Issues in AIDS Research

1 page Project Summary to follow
RELEVANCE (See instructions):
HIV/AIDS continues to be a major health challenge worldwide. The statistical methods which will be
developed under this proposal will lead to more efficient clinical trials, better characterization of the
epidemic and more effective laboratory studies of HIV, and will be relevant to other infectious diseases as
well.

Public health relevance
RELEVANCE (See instructions): HIV/AIDS continues to be a major health challenge worldwide. The statistical methods which will be developed under this proposal will lead to more efficient clinical trials, better characterization of the epidemic and more effective laboratory studies of HIV, and will be relevant to other infectious diseases as well.